Mentoring Multidisciplinary Research in MDR-TB Adherence and the Emergent Drug Resistance

ABSTRACT
Tuberculosis (TB) continues to pose a significant threat to individuals living with HIV,
representing a leading cause of mortality worldwide. Despite advancements in treatment,
approximately 8.2% of new TB cases globally occur in HIV co-infected persons, with an alarming
rise in multidrug-resistant TB (MDR-TB) cases, especially in regions like southern Africa. As a
leader in translational research on drug-resistant TB, I am dedicated to mentoring future clinical
investigators in patient-oriented research, particularly in the context of HIV treatment.
This proposal aims to train a new cadre of researchers equipped with translational, clinical, and
behavioral science expertise to address the challenges of MDR-TB within the global HIV
epidemic. Leveraging my research experience and current funding, the specific aims of this K24
grant are to investigate baseline and emergent resistance to new TB drugs, optimize MDR-TB
HIV treatment by identifying high-risk populations, and characterize pre-existing reservoirs of
drug resistance using population genomics.
Through innovative approaches integrating clinical, translational, and behavioral science
methods, this research aims to fill critical gaps in our understanding of drug-resistant TB
management, particularly in HIV-affected populations. A multidisciplinary team with expertise in
various fields will provide diverse opportunities for student and trainee involvement. The
proposed mentorship-driven research will empower the next generation of patient-oriented
researchers to develop effective strategies for combating drug-resistant TB, ultimately improving
care outcomes in resource-limited settings.

Public health relevance
NARRATIVE Tuberculosis (TB), particularly in people living with HIV, remains a significant global health challenge, with a rising incidence of multidrug-resistant TB (MDR-TB), especially in regions like southern Africa. This Mid-Career Investigator Award will provide Dr. O’Donnell with protected time to mentor and train a new cadre of patient-oriented researchers in translational, epidemiologic, and behavioral methods to tackle MDR-TB within the context of the HIV epidemic, and aims to advance our understanding of the diagnosis, genomic mechanisms, and population distribution of Mycobacterium tuberculosis resistant to new MDR-TB drugs.